Physiology of Single Synaptic CNS Terminals

Abstract
Mammalian brains are extremely sensitive to metabolic perturbation. If blood glucose drops by only a factor of
~2, immediate neurological symptoms emerge, including delirium and coma. We identified nerve terminals as
a one of the likely loci of this vulnerability, as the vesicle recycling program crashes very quickly upon fuel
withdrawal. We hypothesize that this metabolic sensitivity may lie at the heart of both neurodegenerative and
neuropsychiatric diseases, as brain hypometabolism is a strong predictor of the onset of these diseases
(albeit on different time scales). We seek to address many fundamental knowledge gaps we have
concerning how local synaptic metabolism is regulated, including what molecular machineries for
metabolism support synapse function and how different metabolic fuels can be used to support synapse
function. We recently determined that one of the ten enzymes needed for glycolysis serves as a critical
control point for glycolytic flux in nerve terminals. Enhancing the activity of his enzyme, PGK-1, only 2-fold is
sufficient to provide dramatic protection against hypometabolic synaptic dysfunction. We recently discovered
that synapses contain the necessary machinery to both synthesize and utilize lipid droplets, and that they
normally constantly burn through these lipid droplets to sustain synapse function. Mutations in the key
triglyceride lipase required to lipid droplet use are drivers of neurological disease, including intellectual
disability. Similarly, we have recently uncovered a new role for neuromodulators at nerve terminals: in
addition to directly controlling synapse function, they serve as signals to tell synapses to either store or use
glycogen. Our aims to examine how difference cell biological machineries in synapses allow fuel switching
and how perturbations in these machineries drive or heighten neurological disease states.

Public health relevance
The brain is very vulnerable to metabolic problems and synapses, the machinery that mediates the conversion of electrical information into chemical information, are very sensitive to metabolic imbalances. Since neurodegenerative diseases results in improper function of synapses, we hypothesize that these disease states might have at their origin an imbalance between fuel availability and fuel use at the level of individual synapses. The fuel here that matters is a molecule called ATP and our work aims to understand how it is produced at synapses, who consumes it and how in diseases like Parkinson’s and Alzheimer’s this changes.